Precision Lifestyle Medicine and Translation Research (PREMIER)

PROJECT SUMMARY/ABSTRACT
This T32 renewal application seeks continued support for the Precision Lifestyle Medicine and Translation
Research (PREMIER) training program at the University of Illinois Chicago (UIC). The program impact goal is
to build a transdisciplinary, translational research training infrastructure for postdoctoral fellows who aspire to
be both independent investigators and team scientists in precision lifestyle medicine. Specifically, the program
will train highly talented and motivated postdoctoral scholars to be future leaders in research addressing the
prevention and control of cardiovascular and respiratory chronic conditions and comorbidities. The specific
aims are to: (1) Recruit and train a superb and diverse cadre of fellows; (2) Provide an academic “incubator”
for an inspiring mentored research experience and individualized professional development; and (3) Sustain a
pipeline of dedicated, skilled mentors at all academic ranks. PREMIER has 3 integrative scientific foci:
Behavioral Sciences for Multimorbidity Prevention and Control as the central, patient-oriented research
focused core; and the Mechanisms of Behavior Change and Disease and the Population Health Equity and
Policy cores traversing the central core. Supported by the Internal and External Advisory Committees, the
Executive Committee, consisting of the 2 MPIs and the 2 co-leaders of each scientific core, will provide
intellectual leadership and programmatic oversight. These 8 faculty along with 27 others from 6 science
colleges at UIC (Medicine, Public Health, Applied Health Sciences, Nursing, Computer Science, Liberal Arts
and Sciences) are PREMIER mentors. Collectively, they bring deep research and mentorship expertise,
extensive professional experiences, and essential resources. Building on successes to date, the renewed
program will support 12 full-time postdoctoral trainees in years 6-10, with enhanced diversity of the Executive
Committee, expanded training faculty across all 3 scientific cores, and addition of faculty expertise and training
resources in data sciences and methods. Every fellow will receive group mentorship from 1 primary mentor
associated with the core of central interest to the fellow and 1-2 secondary mentors from either or both of the
other cores. One of the mentors must have established expertise in Behavioral Sciences for Multimorbidity
Prevention and Control. Fellows will devote at least 75% effort to mentored research, supplemented by
conferences, seminars, and coursework (which, when appropriate, may lead to a master’s degree, such as a
Master of Science in Clinical Translational Science) based on individual needs. Fellows will be selected from a
national pool of MD and PhD (or equivalent) applicants seeking research training at UIC, which qualifies as a
minority-serving higher education institution. Selection criteria focus on past accomplishments and especially
on their potential as future researchers and educators, and training under-represented minority (URM) scholars
is a priority. Each trainee will develop an individual development plan (IDP), and progress is to be continuously
monitored and formally evaluated. A multi-level evaluation plan is designed to ensure high quality training.

Public health relevance
PROJECT NARRATIVE We seek continued funding support for training future scientists with MDs and/or PhDs (or equivalent) to develop transdisciplinary team science expertise in behavioral sciences for multimorbidity prevention and control, mechanisms of behavior change and disease, and population health equity and policy. These trainees will make discoveries during and after their training that will advance the science and practice of lifestyle behaviors and behavior change for the prevention and control of health conditions involving the heart, lung and/or blood.